The Role of Androgens in Neurophysiological and Autonomic Function in Male Veterans with Spinal Cord Injury

PROJECT SUMMARY/ABSTRACT
Dr. Jacob Goldsmith is focused on identifying effective therapies to improve neural control of motor and
cardiovascular function in persons with SCI. He completed a two-year postdoctoral fellowship at the McGuire
VA Medical Center in Richmond, Virginia, where he studied electrical stimulation and testosterone (T)
treatment to improve motor and cardiovascular function, as well as for improving quality of life in persons with
chronic SCI. Since November 2022, he has worked at the James J. Peters VA Medical Center, Bronx, NY as a
postdoctoral trainee in the labs of Drs. Noam Y. Harel and Jill Wecht to learn neurophysiological assessments
and cardiovascular autonomic assessments in persons with SCI, respectively. Over his research career, Dr.
Goldsmith has displayed an extraordinary commitment to improving the health and welfare of Veterans with
SCI. He has served as first-author or co-author on an impressive list of publications given his early stage of
professional development: 20 published articles (first author on three), one first author review article, two
book chapters. In addition, he has presented at numerous regional and national conferences, as well as the
national VA Grand Rounds. The current proposal focuses on assessing the relationships between circulating T,
nerve function, and cardiovascular autonomic function in male Veterans with SCI. Hypogonadism (low T) is a
prevalent issue in men with SCI, which may exacerbate the deleterious consequences of SCI. There is evidence
that testosterone replacement therapy (TRT) positively influences body composition and energy expenditure,
although there is little to no research examining the associations between endogenous T concentrations and
neural and cardiovascular autonomic function after SCI. This is particularly relevant as several lines of human
and animal research have indicated that normal T is crucial for optimal neural and cardiovascular health and
function in males. Intranasal TRT delivery represents a useful tool to quickly elevate circulating and central
nervous system T concentrations. Moreover, intranasal TRT appears to possess a reduced risk profile and may
facilitate the maintenance of fertility compared to other TRT delivery methods. However, the effects of
intranasal TRT on corticospinal excitability and cardiovascular autonomic function are unknown in any
population. The current CDA-1 proposal will examine associations between endogenous total T and its
subfractions (free and bioavailable T) and neural control of motor and cardiovascular function in male
Veterans with SCI. In addition, an Exploratory Aim will determine the acute effects of a single dose of
intranasal TRT versus placebo on corticospinal excitability and cardiovagal reflex function in men with SCI
who exhibit low T. We hypothesize that the endogenous total T and/or its subfractions will predict
corticospinal and cardiovagal function in men with SCI (Aim 1). Because the Exploratory Aim is a
pilot/feasibility study, hypothesis testing is not appropriate. However, based on the literature we do expect
increasing circulating levels of T into the high normal physiologic range will result in improved neural and
cardiovagal function. To foster his career development within VA, Dr. Goldsmith will receive hands-on
research training related to assessments of central nervous system excitability and cardiovagal reflex function,
extensive mentoring from a stellar mentorship team comprised of experts in the SCI research field, and he will
complete academic coursework, and attend and present at SCI-related research seminars. This research, career
plan, and mentorship team will provide Dr. Goldsmith with the opportunity to develop new skills necessary to
grow into an independent VA career scientist.

Public health relevance
PROJECT NARRATIVE Spinal cord injury (SCI) disrupts the nerves controlling movement, along with those that regulate functions like heart rate and blood pressure (known as the autonomic nervous system, or ANS). Testosterone (T) plays a significant role in brain health and ANS reflex function in non-neurologically impaired men. However, little is known about the relationships between T, nerve function, and ANS dysfunction after SCI. Interestingly, up to 60% of men with SCI exhibit persistently low T concentrations, which may worsen nerve and ANS dysfunction. In uninjured eugonadal people, a single pharmacologic dose of intranasal T has been shown to quickly improve nerve function, but no study has evaluated if T administration alters nerve and ANS function in men with SCI. Herein, we will conduct the first study to assess the relationships between circulating T and motor and ANS function in male Veterans with SCI. We will also conduct a pilot study in a subset of men with SCI and low T, to test how a single dose of intranasal T impacts motor and ANS function in this population.